Immunology Research Training

ABSTRACT
Originally awarded in 1976, this application requests a five-year renewal of the T32 Training Program in
Immunology at the Sloan Kettering Institute, Memorial Sloan Kettering Cancer Center (MSK). The objective of
this Training Program is to provide junior postdoctoral fellows a solid foundation in the field of Immunology and
to direct their interests towards important aspects of the immune system and its response to infectious agents,
self antigens, and cancer. Three postdoctoral positions are requested for this competitive renewal. The
duration of training for each trainee will be up to three years. The Training Program provides trainees with the
intensive training, resources and experience necessary for them to develop successful careers in academia,
government, and industry as independent researchers, mentors, and leaders. Areas of research training
include tumor immunity and immune-oncology, bone marrow transplantation, lymphocyte and myeloid cell
differentiation and biology, cell signaling, microbiota-host interactions, innate immunity, infectious immunity
with a focus on cancer patients related infections. The objective of the Training Program is achieved by
providing a structured environment with intensive involvement in immunology research, further strengthened by
attendance at weekly seminars and research-in-progress meetings, monthly research colloquia and
translational research seminars and an annual retreat. Trainees are also expected to participate in advanced
courses covering contemporary topics of immunology and workshops on bioinformatics and grant writing skills.
The major part of the training comes from the research experience under the tutelage of preceptors who are
engaged in cutting-edge immunology research, with bearing on cancer and tumor immunity and related
aspects of immune cell development and function at molecular, cellular and organismal levels. Trainees will be
also taking advantage of the extensive interdisciplinary collaborations between members of the Immunology
Training Program and respected outside scientists, both locally and nationally.

Public health relevance
PROJECT NARRATIVE Among the major health problems afflicting the US populace today cancer and related diseases have become particularly prevalent. The Immunology Taining Program we propose will train a new cohort of postdoctoral scientists in immunology, with an emphasis on learning how the immune system interacts with tumor cells and how to mobilize the immune system to attack tumors. There have been recent remarkable successes in clinical trials in modulating the immune system to effectively treat cancer in humans, and our goal is to train new scientists to continue and expand this approach to cancer therapy.